RCT on Wheeled Mobility for Preventing Pressure Ulcers

Abstract Pressure ulcers are a significant healthcare problem for the growing number of older long-term care (LTC) residents in the United States and around the world. Pressure ulcers diminish quality of life, exact a devastating loss of function, increase the risk of death in geriatric populations and raise healthcare costs. Costs for the management of pressure ulcers in the US likely exceeds $6.4 billion annually, with a prevalence of approximately 12% in the high risk LTC population. At Pitt, we have been studying the effects of seat cushions on pressure ulcer incidence and have found that when a skin protection seat cushion is used with a properly fitted wheelchair there is a significant reduction in incidence. Our data has now led us to question whether having a properly fitted wheelchair also has a significant effect on pressure ulcer incidence. To investigate this question, we are proposing a new study, RCT Wheelchair 2 (RCT-WC2), in which subjects will be randomized into a control group that receives a skin protection cushion and wheelchair training for use in their facility supplied wheelchair, or a treatment group that receives a skin protection cushion, wheelchair training and a new custom-fitted wheelchair. We expect that the treatment group will have a lower incidence of pressure ulcers.

Public health relevance
Project Narrative The proposed clinical trial is aimed at demonstrating the important role wheelchairs play in preventing pressure ulcers (bed sores). Although most pressure ulcers can be prevented, they are common in nursing home settings because their causes are difficult to identify. The proposed trial, if successful, will guide practitioners toward improving preventive care practices by demonstrating how to effectively apply wheelchair and seat cushion technology __SpecificAimsTextDelimiter__ 2.0 Specific Aims Pressure ulcers (PU) are a significant healthcare problem for the growing number of older long-term care (LTC) residents in the United States and around the world. PUs diminish quality of life, exact a devastating loss of function, increase the risk of death in geriatric populations and raise healthcare costs. At Pitt, we have been studying the effects of wheelchair seat cushions on pressure ulcer incidence and have found that when a skin protection cushion is used with a properly fitted wheelchair there is a significant reduction in incidence. Our data has now led us to question whether having a properly fitted wheelchair also has a significant effect on pressure ulcer incidence. To investigate this question, we are proposing a new clinical trial, RCT Wheelchair 2 (RCT-WC2), in which subjects will be randomized into a control group that receives a skin protection cushion for use in their facility supplied wheelchair and wheelchair skills training, or a treatment group that receives a skin protection cushion, new custom fitted wheelchair, and wheelchair skills training. Our hypothesis is that the treatment group will have a lower incidence of pressure ulcers. The primary aim of our RCT on preventing pressure ulcers with seat cushions (5 R01HD041490) was to determine the efficacy of skin protection cushions in preventing sitting-acquired pressure ulcers in the elderly LTC population. Our study was successful. We found that the use of a skin protection cushion (SPC) with a properly fitted wheelchair reduced the incidence of pressure ulcers (p<0.04). A properly fitted wheelchair was provided to both the treatment and control groups to allow for comparison of the effects of cushion type (skin protection vs. standard foam), and to be consistent with best practice in wheeled mobility. However, in practice, most LTC residents use facility-supplied fleet wheelchairs for mobility. Daily availability of properly fitted wheelchairs is unpredictable and rare. As a result, residents are often forced to use misfit wheelchairs. Misfit wheelchairs place them in poor postures, reduce their function and limit their mobility. Poor posture, especially the posterior pelvic rotation that occurs in wheelchairs that are too big, leads to high pressure at the sacrum and ischial tuberocities. Decreased mobility leads to inactivity and discourages self-propulsion. In our RCT on Seat Cushions (RCT-SC), we found that in residents that could self-propel, 6.4% developed pressure ulcers vs. 19.5% in those who could not self-propel (p<0.02). Similarly, we found that in those subjects who could reach and carryout tasks at different surface heights (independent), 6.6% developed pressure ulcers vs. 19.2% in those who were dependent. Since a study group that did not receive a properly fitted wheelchair was not part of RCT-SC, we cannot distinguish between the effects of the wheelchair compared to the effects of the seat cushion. However, the differences observed in PU incidence related to propulsion and function suggest that the wheelchair may have an effect on incidence. RCT- SC showed that standard cushions used with properly fitted wheelchairs resulted in higher pressures that in turn led to a higher incidence of PU development. RCT-Wheelchair 2 (RC-WC2) aims to show that misfit wheelchairs, even when used with skin protection cushions, result in poor posture and/or positioning that either leads directly to high pressure and PUs, or decreases propulsion and reach independence, promotes inactivity and immobility that in turn leads to extended bouts of Figure 1 - Illustration showing how standard cushions high pressure and pressure ulcers (see Figure 1). and misfit wheelchairs may lead to of PUs. Positive results of the proposed RCT-WC2 study will provide a level of evidence needed to change the standard of care in LTC to include the routine evaluation of at- risk residents for seating and positioning needs and the provision of a properly fitted wheelchair with a skin protection cushion as a preventive measure against sitting-acquired pressure ulcers. If our hypothesis is correct, such an intervention should result in a decrease in the incidence and prevalence of sitting-acquired pressure ulcers, reduced healthcare costs, and improved quality of life.